Administrative Core

PROJECT SUMMARY
Towards the overall theme of translating basic research into new treatments for skin disease, the goals of the
Penn SBDRC are to promote multi-disciplinary, collaborative research among skin investigators; draw new
investigators with diverse perspectives to skin research; foster an interactive, multi-disciplinary environment
that cultivates the next generation of skin researchers; increase access to state-of-the-art approaches and
resources for conducting rigorous skin research, and accelerate translation of research findings into innovative
therapies for skin disease. In addition to providing state-of-the-art service offerings through 3 Resource Cores,
the Penn SBDRC includes an Administrative Core, which unifies skin researchers across the University, the
Philadelphia region and beyond. The Aims are: 1) To provide oversight and evaluation of the Penn SBDRC; 2):
To coordinate, integrate, and communicate the activities of the Penn SBDRC. The Administrative Core
provides administrative, logistical, regulatory, and financial support to the overall Center, the Resource Cores,
and the Enrichment Programs. The SBDRC website and its underlying REDCap databases serve as the major
platform for interacting with members, including ordering of Core services, tracking membership data,
evaluating services and programs, tracking outcomes, and relaying announcements such as seminar and
meeting notices. A quarterly SBDRC Newsletter and Twitter feed are additional tools for disseminating
information and highlighting the research and achievements of SBDRC members. 3) To implement an
Enrichment Program that enhances the scientific environment and supports the next generation of skin
researchers. The SBDRC Enrichment Program is divided into four Sub-Cores representing individual
objectives: (a) The Scientific Enrichment Sub-Core sponsors an Annual Scientific Symposium, seminars, and
workshops. (b) The Community Outreach Sub-Core introduces underserved Philadelphia public high school
students to the excitement of scientific research and dermatology through the Penn Academy of Skin Health
(PASH), a Saturday academy program and summer internship program. (c) The Mentoring Sub-Core promotes
the career success and training of a diverse pool of future skin researchers through structured mentoring for
senior trainees and junior faculty, and specialized mentoring programs for women and minorities
underrepresented in medicine. (d) The Seed Funding Sub-Core offers 3 different funding mechanisms that
attract new investigators and foster the independence of junior investigators.